FOXA1 loss-of-function induces inflammatory cytokine signaling and immune suppression in prostate cancer

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PCa) is the most commonly diagnosed cancer and second leading cause of cancer
death in American males. Androgen deprivation therapies extend patient lifespan, but can result in progression
to castration resistant prostate cancer (CRPC). Moreover, treatment with next generation antiandrogens often
results in further resistance and differentiation to neuroendocrine prostate cancer. Recently, immunotherapies,
such as immune checkpoint inhibitors, have become an area of much interest. However, CRPC has shown a
poor response to immune checkpoint inhibitors, due to its immunosuppressive nature. Thus, we need a better
understanding of how genetic alterations commonly seen in advanced PCa shape the tumor immune
microenvironment (TIME), in order to inform the design of better-targeted immunotherapeutic approaches. We
here propose to investigate the role of epithelial transcription factor Forkhead Box A1 (FOXA1) in regulating the
TIME in PCa. FOXA1 is found to be downregulated in CRPC, and is among the most highly mutated genes in
PCa. In accordance, we have previously shown that FOXA1 loss or mutation induces epithelial-mesenchymal
transition and metastasis. However, whether FOXA1 loss-of-function induces an immunosuppressive TIME
in PCa remains poorly understood. In preliminary studies, we noticed that inflammatory cytokines, such as
CCL2, TGFB3, and IL8, which are associated with recruitment of immunosuppressive myeloid derived
suppressor cells and tumor-associated macrophages, were among the most highly upregulated genes upon
FOXA1 depletion or mutation. In our investigation of the mechanism by which FOXA1 represses the expression
of inflammatory cytokines, we identified ARID1A as a FOXA1 co-repressor. Notably, we found FOXA1 and
ARID1A proteins interacted and exhibited extensive co-occupancy on the chromatin in PCa cells. Moreover,
ARID1A repressed genes were also enriched for inflammatory pathways. Thus, we hypothesize that FOXA1
loss or mutation in PCa unleashes ARID1A and induces epigenetic reprogramming and inflammatory
cytokine signaling, thereby promoting an immunosuppressive tumor microenvironment and PCa
progression. We here propose to: (1) decipher the molecular mechanisms by which wild type and mutant
FOXA1 regulate inflammatory cytokine signaling, and (2) determine the extent to which FOXA1 loss or mutation
induces an immunosuppressive tumor microenvironment in PCa.

Public health relevance
PROJECT NARRATIVE Epithelial pioneer transcription factor FOXA1 (Forkhead Box A1) is frequently mutated or downregulated in advanced prostate cancer. While previous studies have established FOXA1 functions in repressing epithelial- mesenchymal transition, metastasis, and neuroendocrine de-differentiation, the role of FOXA1 in regulating the tumor immune microenvironment is poorly understood. The objectives of this project are to study the roles of FOXA1 loss or mutations in inducing tumor infiltration by immunosuppressive cells and elucidate the underlying molecular mechanisms, in order to identify vulnerabilities that can be targeted to improve prostate cancer patient care.